Brain Wide Anesthetic-Active Neuronal Network

Abstract
Anesthetics are low affinity drugs that interact with hundreds of molecular targets present throughout the
nervous system at clinically significant concentrations. Despite this molecular-level promiscuity, the hypnotic
effects of anesthetics depend critically on specific neural circuits. This assertion is supported by numerous
results showing that direct modulation of specific sites distributed broadly throughout the brain can potentiate
or, conversely, antagonize the anesthetic state. However, because previous experimental work focused upon
one brain site at a time, the identification of the long-hypothesized brain-wide canonical anesthesia circuit has
so far remained elusive. To fill this critical gap in knowledge, we reasoned that ultimately, the state of
anesthesia must be imposed onto the brain by neurons that remain active under anesthesia, while most other
neurons are suppressed. To identify anesthetic active neurons throughout the brain, we used tissue clearing
and 3D c-Fos immunohistochemistry. We validated that putative anesthesia-active neurons are indeed
physiologically active in vivo using two photon microscopy and fiber photometry. Having identified anesthesia-
active neurons, we further reasoned that brain regions which project broadly are more likely to play a pivotal
role in modulating the level of consciousness. Thus, we combined our brain activity map with whole brain
connectivity analyses. The potent combination of these experimental and bioinformatics approaches allowed
us to identify regions that contain a high density of anesthetic-active neurons and project broadly throughout
the brain. Our unbiased approach culminated in the definition of a putative canonical anesthesia network
comprised of nuclei in the ventral hypothalamus, thalamus, and the prefrontal cortex. In Aim 1, we will discover
the specific cell types within prefrontal cortex, ventral hypothalamus and thalamus that remain active under
anesthesia. This is of critical importance as all brain regions contain many cell subtypes with distinct
neurophysiological properties, connectivity patterns, and ultimately, behavioral effects. In Aim 2, we will
discover the brain-wide projections made by anesthetic-active neurons by combining anterograde and
retrograde viral tracing in transgenic mice that specifically label distinct neuronal subtypes with 3D
immunohistochemistry. In Aim 3, we will establish the functional roles of the canonical anesthesia network as a
whole and each of its elements individually by combining chemo- and optogenetics with behavioral and
neurophysiologic assessments of arousal. The ultimate result of the proposed research will be the identification
of a canonical network of neurons sufficient to elicit hypnosis. This has fundamental implications for how the
state of arousal is controlled in health and dysregulated in disease. Identification of this circuit may also
suggest druggable targets for the development of more specific anesthetic agents with fewer undesirable
effects. This has the potential to significantly improve the care of millions of patients requiring general
anesthesia for life saving procedures.

Public health relevance
Narrative Millions of patients undergo procedures requiring general anesthetics – drugs whose effects on the brain remain poorly understood despite continuous use for over a century. This innovative proposal combines whole brain imaging at cellular resolution with cutting edge techniques for monitoring and modulating brain activity to ultimately identify the neurons and circuits responsible for the establishment of anesthetic-induced unconsciousness. Such detailed understanding of the unconscious state is a necessary pre-requisite for improving upon existing anesthetics and will reveal the fundamental mechanisms that control the level of consciousness in health and disease.